Rewiring of epigenetic DNA damage response pathways in HPV-induced cancer

Project summary/abstract
Infection with human papilloma virus (HPV) causes endemic occurrence of cervical, head and neck and anal
cancers. Radiotherapy is the cornerstone treatment for these tumors. However, clinical outcomes in patients with
locally advanced disease remain poor due to high recurrence rates. Thus, there is a critical need to improve the
efficacy of radiation in these tumors. Epigenetic signaling pathways play a crucial role in DNA damage response
providing suitable clinical targets for improving the efficacy of radiotherapy. We demonstrate that expression of
the HPV proteins E6 and E7 alters epigenetic signaling in cancer cells. We hypothesize that these epigenomic
alterations cause tumor dependence on alternative epigenetic pathways to cope with DNA damage. Using a
CRISPR/Cas9 screen we discovered that HPV-positive cancer cells selectively depend on the chromatin modifier
NSL1 and the E3 ubiquitin ligase RNF168 to survive radiation. The goal of this proposal is to determine the
mechanisms of DNA damage response (DDR) regulated by these pathways in the setting of HPV-induced
epigenetic changes. Our work will establish a novel concept of tumor-targeted therapy by harnessing HPV-
induced epigenomic alterations to allow specific targeting of cancer cells while sparing healthy tissues. The work
proposed here will be conducted under the mentorship of Dr. Dennis Hallahan, a leader clinical and experimental
radiation oncology. The candidate is an MD/PhD with training in clinical radiation oncology who seeks further
training in basic research. His long-term goal is to establish an independent research laboratory studying the
role of epigenetics in DDR. It is anticipated that the project will result in impactful contributions to the fields of
DDR and Radiation Oncology and prepare the candidate for a career as an independent investigator.

Public health relevance
PROJECT NARRATIVE The research proposed in the project will investigate the molecular mechanisms that cancer cells use to survive radiation therapy. The insights gained from these studies will lead to the development of novel treatment strategies for cancer patients.